Epigenetic Reprogramming to Counteract Neuronal Aging and Degeneration

Project Summary/Abstract
The aging brain is increasingly susceptible to cognitive decline and dementia. Alzheimer’s disease (AD), a main
form of dementia, is an extreme, pathological manifestation of brain aging. However, the etiology and
pathogenesis of AD are not well understood, causing the dearth of effective treatments. Mounting evidence has
implicated epigenetic changes, such as DNA methylation and histone acetylation, in neuronal aging and
degeneration, raising the hypothesis that resetting these epigenetic changes and restoring a youthful epigenome
may increase neuroplasticity and forestall disease. We have recently discovered that epigenetic reprogramming
by coexpression of three Yamanaka factors, Oct4, Sox2, and Klf4 (OSK), can induce axon regeneration in retinal
ganglion cells (RGCs), a type of central nervous system (CNS) neuron, after acute injury. Furthermore, OSK
expression in RGCs of old mice reversed aging-associated transcriptome changes, reset the DNA methylation
age of the cells, and restored vision to a level similar to young mice, suggesting neuronal rejuvenation.
Importantly, cell cycle, cell identity, and intrinsic electrophysiological properties of postmitotic neurons were not
affected by OSK reprogramming. In this proposal, I seek to identify the epigenetic mechanisms that underlie
OSK-mediated axon regeneration (Aim 1), determine whether epigenetic reprogramming in brain neurons
reverses age-associated cognitive decline and epigenomic changes (Aim 2), and investigate the role of
epigenetic changes in the progression of AD (Aim 3). A new mouse model that allows temporal control of
epigenetic reprogramming in the forebrain neurons will be used to evaluate the therapeutic effect of epigenetic
reprogramming in AD through a combination of molecular, physiological, behavioral, and histological techniques.
Based on our preliminary results, I hypothesize that reversal of the aging epigenome in CNS neurons will improve
neuronal plasticity and restore cognitive function that are impaired due to aging and Alzheimer’s disease. This
work will provide novel insights into the etiology of AD, identify the epigenetic links between aging and AD, and
may reveal a new realm of therapeutics. Aims 1 and 2 will be performed predominantly during the K99 phase
under the mentorship of Dr. David Sinclair, a leader in aging and epigenetics; Dr. Edward Boyden, a world-
renowned neuroscientist; and Dr. Steve Horvath, an expert in DNA methylation and aging. Aim 3 will be
performed predominantly during the R00 phase. The mentorship program and proposed research will allow me
to gain rigorous scientific training in neuroscience and bioinformatics, specializing in neurodegeneration,
neurophysiology, and genome-wide epigenetic analysis. In addition, in conducting the K99 phase at Harvard
Medical School, my work will benefit from the highly collaborative research environment, state-of-the-art
technologies and facilities, and world-renowned experts available for collaboration and consultation. The award
will enable an in-depth career development plan for me to expand the scope of my research and launch an
independent research program focused on studying epigenetic mechanisms of neuronal aging and degeneration.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is a prevalent age-related disorder which imposes tremendous impact on patients, families, and public health, as there are currently no therapies to prevent it, cure it, or slow its progression. Our recent study has discovered an epigenetic reprogramming strategy that can rejuvenate aged epigenome in postmitotic neurons, promote neuronal survival, and induce axon regeneration. This project aims to understand the role of epigenetic dysregulation in neuronal aging and degeneration in the brain, and test the therapeutic effect of epigenetic reprogramming on the progression of AD.